Multimodal regulation of intracellular lipid surveillance

Project Summary/Abstract
Lipid signaling is crucial for regulating organismal physiology and metabolic expenditure, and disturbances in
lipid homeostasis can deleteriously impact health. Cells tightly control the absorption, synthesis, and breakdown
of lipids to accommodate energetic demands and ensure energetic reserves later in life. We recently reported a
mechanism by which cells sense metabolic demand resulting from lipid depletion and respond by increasing
expression of genes involved in membrane trafficking as well as nutrient absorption and catabolism. This is
accomplished by the release of the starvation-responsive nuclear hormone receptor, NHR-49, from endocytic
vesicles and its subsequent nuclear translocation and transcriptional activation. Yet the mechanisms and
participating co-factors facilitating NHR-49 activation and attenuation remain unclear and are critical for
our fundamental understanding of lipid sensing and metabolism. Our examination has uncovered a
mechanism in which loss of antagonistic ligand binding releases NHR-49 from endocytic vesicles. Next, NHR-
49 sequentially engages a series of cofactor, which through direct interactions and post-translational
modifications, facilitate its nucleocytoplasmic shuttling, transcriptional activation, and proteolytic degradation.
Through the proposed five-year research period, we aim to understand how cells activation and attenuation this
lipid surveillance response by defining the molecular details underlying the lifecycle of NHR-49 including its
nuclear import, intranuclear retention, and transcriptional regulation followed by its phosphorylation, nuclear
export and degradation. Our preliminary data has identified a series of co-factors including karopherins involved
in its nucleocytoplasmic shuttling, nuclear pore complexes involved in its nuclear retention and transcriptional
activation, kinases involved in its nuclear export, and a ubiquitin ligase involved in its proteasomal degradation.
Through a more detailed description of NHR-49 co-factor interactions and their associated post-translational
modifications, we can gain a better understanding of intracellular lipid sensing and metabolic homeostasis.

Public health relevance
Project Narrative Imbalances in lipid homeostasis can deleteriously impact health and therefore cells within the organism tightly regulate absorption, synthesis, and metabolism to accommodate energetic demands and ensure energetic reserves later in life. My laboratory has identified a mechanism by which cells sense intracellular lipid depletion and respond to metabolic demand. Activation and attenuation of this lipid surveillance response is regulated by the starvation-responsive nuclear hormone receptor, NHR-49, and a series of co-factors which mediate its vesicular release, nuclear import, intranuclear retention, and transcriptional activity followed by its phosphorylation, nuclear export and proteasomal degradation.